RSVIG IV TO REDUCE RSV ADMISSIONS OF BRONCHOPULMONARY DYSPLASIA INFANTS

This is a Phase III, randomized, double-blind, placebo-controlled, multi-center trial to establish whether RespiGam(R) is effective as RSV immunoprophylaxis in infants born prematurely and those with bronchopulmonary dysplasia.